Examining Intensive Outpatient Programs as a Potential Mechanism to Reduce Suicide Risk During the Post-Hospitalization Period Among Medicaid Recipients

ABSTRACT
Suicide is a top ten cause of mortality in the United States, and suicide rates have increased dramatically in
recent decades. A recent meta-analysis showed that the suicide rate following discharge from a psychiatric
facility was 2,078 per 100,000 person-years (versus 14.0 for the general population). Approximately one-
quarter of all suicide deaths occur within 3 months of discharge from a psychiatric facility, making this a period
of extremely high risk.
With the advent of managed care in the 1990s and the concomitant decrease in hospital lengths of
stay, Intensive Outpatient Programs/Partial Hospitalization Programs (IOP/PHPs) were instituted to manage
high-risk patients outside of a locked hospital unit. Today, IOP/PHP services are frequently used in some areas
as the principal discharge plan for patients upon leaving the hospital. However, there is virtually no evidence
examining their clinical effects on suicide risk in this period. While these IOP/PHP services are readily available
in some areas of the country, they are virtually non-existent in other regions. If IOP/PHP services have a
significant protective effect against suicide following hospital discharge, implementation initiatives to broaden
the availability of these services nationwide could be undertaken as a way to bend the curve against suicide.
We hypothesize that the intense social and psychological support of IOP/PHPs will be reflected in a
reduction in suicide risk among patients who receive treatment through these programs. We will test this
hypothesis by conducting a propensity score matched observational study of patients who receive treatment at
IOP/PHP services following discharge compared to patients who receive non-intensive outpatient follow-up.
Cohorts for these groups will be sufficiently large (over 100,000 per group) to detect even small differences in
suicide rates between intervention groups (minimum detectable rate ratio ranging from 0.82 to 0.95, see Table
4). The data for this project will be drawn from Medicaid databases and will be linked with the National Death
Index, the most authoritative data source for mortality in the United States.
Additionally, we will conduct a national survey of clinical directors of IOP/PHP services to identify and
characterize clinical care processes. Survey results will be integrated with claims-based analyses to better
understand what care processes may be effective in reducing suicide risk following hospital discharge as well
as to understand the variations in quality of care throughout the country among IOP/PHP services.
Results from this project would have important implications for policy and discharge planning patterns
in the post-hospitalization period. Future directions would include dissemination and implementation initiatives
to align discharge planning patterns with clinical evidence. A stakeholder council will be formed during the
project to help implement strategies to enhance the availability of these services in locations where they are
not widely accessible.

Public health relevance
Narrative Approximately one-quarter of all suicides occur among patients who are within 3 months of discharge from a psychiatric hospital. Intensive outpatient programs/partial hospitalization programs (IOP/PHPs) have been instituted to help care for high-risk patients who do not fully require 24-hour supervision, but there is a tremendous amount of regional variation in access; while IOP/PHPs are readily available in some regions of the United States, they are virtually nonexistent in others. Using linkage with the National Death Index, this project will examine the effectiveness of IOP/PHP as a service intervention to reduce the risk of suicide death in the post-hospital discharge period compared to standard outpatient follow-up care among Medicaid recipients.